INFLUENCE OF AGE ON THEOPHYLLINE PHARMACOKINETICS/METABOLISM IN COPD

To test the hypothesis that age related decrease in theophylline metabolism is the consequence of specific metabolic pathway impairment or alteration and not the result of general, non-specific age-related phenomena.